The nature of Propionibacterium acnes-induced inflammatory immune responses in acne vulgaris

PROJECT SUMMARY/ABSTRACT
New evidence from our studies demonstrates that specific P. acnes ribotypes, distinguished by unique 16S
rDNA, may be associated with either healthy skin (ribotype PH) or acne (ribotype PA). We propose to
investigate the nature of immune mechanisms by which ribotypes PH and PA induce Th1 vs. Th17-mediated
responses. The P. acnes ribotypes PH and PA to be used in this study are the most prevalent and include three
each of PH and PA strains that have been enriched in individuals with healthy skin or associated with the acne
patient group. We will test our central hypothesis that that P. acnes ribotypes trigger T cells that mediate
distinct immune responses, which either contribute to the pathogenesis of acne or lead to a protective
mechanism. In Aim 1, we will use informatics, taking advantage of the publicly available skin database
DermDB to gain insight into the mechanisms of T cell differentiation. Specifically, using RNAsequencing, we
will derive gene signatures of PH and PA-activated innate immune cells, to identify the networks that determine
T cell differentiation into functional Th1 and Th17 cell subsets. We will also determine the mechanism(s),
including cytokine, by which PH and PA induce T cell differentiation. Although the P. acnes genome has been
sequenced, virulence factors and specific ligand(s) that activate immune cells are not clear. We have
previously demonstrated that the Toll like receptor-2 (TLR2) mediates the interaction between antigen
presenting cells and P. acnes. The bacterial ligand(s) responsible for these interactions are potential
therapeutic targets, but are currently unknown. In Aim 2, we propose to use biochemical and proteomic
techniques to identify bacterial ligand(s) from PH and PA that lead to differential immune signatures identified in
Aim 1, and using siRNA knockdown of specific pathogen recognition receptors (PRR), identify the PRRs that
recognize PH and PA to induce the innate cytokines that instruct adaptive immunity. The data generated in Aim
2 will help in the identification of PH and PA ligand(s) that interact with innate PRRs, and provide new insights
into the immunobiology of Th1 and Th17 cells. In Aim 3, we will identify the phenotype and function of Th1 vs.
Th17 cells induced by P. acnes ribotypes PH and PA. Using the informatics approaches outlined in Aim 1 we
have identified IL-26 within the potential new Th17 gene networks. A previously unknown function of Th17-
derived IL-26 as a direct antimicrobial agent and activator of DNA-sensing innate immunity was recently
reported. Here, we will determine the antimicrobial mechanisms of encoded proteins against P. acnes including
IL-26 in in vitro CFU assays, and determine the frequency of IL-26 expressing cells in acne skin specimens by
immunohistology. Our investigations of the mechanisms by which distinct ribotypes of a commensal bacterium
trigger divergent immune responses will have broad applicability to understanding microbiome-host immune
response interactions as well as identify novel targets for immunological intervention. Overall, the K01 training
program will allow me to develop the skills and tools needed to become a successful independent investigator.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Acne, the most common human skin disease, is associated with Propionibacterium acnes, affects over 50 million people in the U.S., and has a significant psychological impact on patients affecting their self-esteem. We hope to identify P. acnes ligand(s) that drive Th1 and Th17-mediated inflammation, and the potential to target this ligand(s) in acne therapy.